ACETYL L CARNITINE IN PATIENT BETWEEN 45-60 YEARS WITH ALZHEIMERS DISEASE

This is a study to evaluate the use of this drug in younger patients; the drug having been studied extensively in all patients over 60. The end result is to accomplish improvement in cognitive and functional testing.